Regulation of ENaC in salt-sensitive hypertension via inflammation-induced ROS pr

DESCRIPTION (provided by applicant): Epithelial sodium channel (ENaC) is a key regulator of sodium homeostasis in aldosterone-sensitive distal nephron (ASDN) controlling body liquid volume and blood pressure. Dysfunction and aberrant regulation of ENaC lead to a spectrum of diseases associated with abnormal sodium handling, ranging from hypo- to hypertension with sodium retention and wasting, respectively, to respiratory syndromes. The studies focused on the role of ENaC in normal and pathological physiology can be translated into clinical practice and fulfill the mission of NHLBI to improve health of the patients. Sodium loading is associated with an increase in blood pressure in normotensive and hypertensive individuals. Dahl salt-sensitive (SS) rats used in this proposal develop severe hypertension on high-salt diet. Our preliminary data indicate that ENaC-mediated Na+ reabsorption in the ASDN contributes to salt-sensitive hypertension in SS rat strain and I hypothesize here that excessive H2O2 production mediates this effect. ENaC subunits expression is inappropriately upregulated in SS rats fed a high salt diet compared to SS rats fed a low salt diet and consomic SS-13BN rats fed a high salt diet. Treatment with ENaC inhibitor benzamil attenuates increase in blood pressure in SS rats. Infiltrating T lymphocytes in the kidney increase oxidative stress and participate in the development of salt-sensitive hypertension in SS rats. Moreover, our preliminary results demonstrate that ENaC activity is upregulated by H2O2 production. I hypothesize that ENaC-mediated Na+ reabsorption in the ASDN plays a role in the development of salt-sensitive hypertension and that activation of immune cells increases generation of H2O2, which correspondingly activates ENaC and participates in the development of salt-sensitive hypertension. It is further hypothesized that increased H2O2 production results in changes of the actin cytoskeleton and that cortactin and MIM proteins are involved in this mechanism. Built upon our preliminary data and previously published findings, the specific objectives of this proposal are to determine whether infiltration increases H2O2 production in the kidney cortex and consequently upregulates ENaC-mediated sodium reabsorption in the ASDN and define the precise mechanisms of H2O2-mediated changes in ENaC activity. A combination of variety approaches will be used in this proposal to provide mechanistic insights on how ENaC is regulated by H2O2 and how changes in this pathway contribute to salt-induced hypertension. These studies will address two Specific Aims: 1) To determine if infiltration of T cells and consecutive H2O2 production in SS rats increases ENaC activity; 2) To define the cellular and molecular mechanism by which H2O2 modulates ENaC activity. My long-term professional goal is to continue my academic career in the field of biomedical research to study ion channels involved in regulation of salt and water balance at the cellular, organ and systemic levels. The K99/R00 grant fits to my career goals providing excellent opportunity to assist in transitioning to a stable independent research position with NIH or other independent research funding.

Public health relevance
PROJECT NARRATIVE The control of blood pressure occurs via Na+ homeostasis in the kidney and involves the precise regulation of the Epithelial Na+ Channel (ENaC) in the aldosterone-sensitive distal nephron (ASDN). The current proposal will study the role of inflammation in the kidney in the development of hypertension. Anticipated results will help to understand how to manage high blood pressure induced by high salt consumption. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Long term control of blood pressure requires appropriate Na+ homeostasis by the kidney, through regulation of the epithelial Na+ channel (ENaC) in the aldosterone-sensitive distal nephron (ASDN). ENaC dysfunction causes imbalance of total body Na+ level associated with abnormal regulation of blood volume, blood pressure, and lung fluid balance14,16,17,43,50,60,64,72,94,98,106-109,115. Dahl salt-sensitive (SS) rats used in this proposal develop severe hypertension on a high-salt diet and it is recognized that reactive oxygen species (ROS), and particularly H2O2, are involved through various mechanisms in the development of salt-sensitive hypertension23,24,81,100,112. The role of H2O2 in the kidney cortex has been largely neglected as most studies focused mostly on the vascular and tubular effects of O 2- and NO. Our preliminary data indicate that ENaC- mediated Na+ reabsorption in the ASDN contributes to the salt-sensitive hypertension in the SS rat strain and we hypothesize here that excessive ROS production mediates this effect. Expression of ENaC subunits is abnormally upregulated in SS rats fed a high salt diet compared to a low salt diet whereas in salt-resistant consomic SS-13BN rats it remains unchanged. Treatment with ENaC inhibitors amiloride and benzamil attenuates the blood pressure raise in SS rats fed a high salt diet. Infiltrating T lymphocytes in the kidney increase oxidative stress and participate in the development of salt-sensitive hypertension in the SS rats30. Furthermore, we provide data indicating that the infiltrating cells are enriched in NADPH oxidase and can serve as a source of intrarenal H2O2, and that genetic mutation of recombination activating gene 1 (Rag1) or chronic immunosuppressive therapy in SS rats decreases immune cell infiltration and attenuates the NaCl-sensitive hypertensive and renal disease phenotype. Our preliminary results, including electrophysiological experiments using isolated, split open ASDN, demonstrate that ENaC is upregulated by H2O2 production. Furthermore, ROS production stimulates ENaC-mediated sodium reabsorption in immortalized principal cells. As illustrated in Figure 1, we hypothesize that ENaC-mediated Na+ reabsorption in the ASDN plays a role in the development of salt-sensitive hypertension and activation of immune cells increases generation of ROS, which correspondingly activates ENaC and participates in the development of salt-sensitive hypertension. We further hypothesize that increased ROS production results in changes of the actin cytoskeleton and that cortical actin binding protein cortactin as well as missing in metastasis (MIM) protein are involved in this mechanism. Built upon our preliminary data and previously published findings53,61,63, the specific objectives of this proposal are to determine whether infiltration increases H2O2 production in the kidney cortex and consequently upregulates ENaC-mediated sodium reabsorption in the ASDN and to define the precise mechanisms of H2O2-mediated changes in ENaC activity. The mechanisms of action of infiltrating T cells will be explored in this proposal using a comprehensive approach with unique newly generated rat models in which Rag1 (SSRag1 null) and the p67phox subunit of NADPH oxidase (SSp67 null) have been mutated in the SS rat background. A combination of electrophysiological, genetic, biochemical and microscopic studies will be used in this proposal to provide mechanistic insights on how ENaC is regulated by H2O2 and how changes in this pathway contribute to salt- induced hypertension. Aim 1. To determine if infiltration of T cells and consecutive H2O2 production in SS rats increases ENaC activity. The role of infiltration and activation of immune cells in the kidneys in the activation of ENaC in the ASDN will be explored. Generated p67phox and Rag1 rat models in which corresponding genes are modified in SS rat background will be used here. NADPH oxidase complex subunits expression, H2O2 production in the kidney cortex and ENaC activity in these rats will be determined. Aim 2. To define the cellular and molecular mechanism by which H2O2 modulates ENaC activity. We hypothesize that H2O2 production modulates ENaC activity. This aim will explore if the actin cytoskeleton and cortactin and MIM proteins are involved in this mechanism. Protocols using isolated ASDN, cultured principal cells and shRNA-induced silencing of the particular proteins are designed to study signaling mechanisms mediating ROS regulation of ENaC. Figure 1. Hypothesis to explain mechanisms of ENaC regulation by increased H2O2 production in response to infiltration participating in the development of salt-sensitive hypertension.